Training in Pediatric Cancer Survivorship Outcomes and Interventions

PROJECT SUMMARY/ABSTRACT
Remarkable gains have been made in the treatment of pediatric cancers over the past 60 years resulting in a
growing population of long-term survivors of childhood cancer that is currently estimated to exceed 500,000.
Many long-term survivors experience chronic health conditions and poor health behaviors, which significantly
contributes to medical burden and impacts functional outcomes and quality of life. Research on long-term
survivors of pediatric cancer is continually informing the design of new treatment approaches for newly
diagnosed patients, with the objective of minimizing long-term therapy-related morbidity and mortality. As the
majority of children diagnosed with cancer will become long-term survivors and will be at risk for experiencing
multiple complications following treatment, continued research is needed to enhance health and functional
outcomes. Future research efforts will require well-trained independent investigators from the fields of oncology,
epidemiology, behavioral and social sciences, biostatistics, cancer biology and genetics, health services, and
other allied health disciplines. While some T32-funded cancer training programs offer training opportunities in
cancer survivorship, few academic institutions possess the resources and large multidisciplinary team that St.
Jude does to provide in-depth post-doctoral research training focusing on pediatric cancer populations.
Currently, we have the only NIH-funded training program with a primary focus on pediatric cancer survivorship.
The purpose of our training program is to develop the next generation of scientific leaders with the
interdisciplinary skills and knowledge that is necessary to become world-class competitive scientists in the area
of pediatric cancer survivorship. The key elements to the program includes: a Scholarship Oversight Team
comprised of primary and secondary mentors and a clinical collaborator; a Management Committee to review
program progress; an Advisory Committee; clinical and research training relating to cancer survivorship and
pediatric oncology; a formal but flexible MSc curriculum in clinical investigation and a MPH curriculum in
epidemiology, biostatistics or health systems policy; training in scientific writing, grant preparation and grant
review; and a detailed evaluation that will track the ongoing progress of the trainees in their subsequent
careers. We have just completed the 4th year of the new program and have graduated four postdoctoral
fellows, three of whom have gone into academia and one into industry. We have a new class of trainees
progressing well. Of note, one of the former trainees and one of the current trainees are under-represented
minorities, Black and Hispanic respectively, and one comes from an economically disadvantaged background.
For this competing renewal, we have significantly enhanced the program with required “light”, and optional
“deep”, experiences in both Global Health, which has been part of the program from the start but is not
formalized. The innovation and uniqueness of the program includes its comprehensive focus on pediatric
cancer survivorship across the lifespan of the survivor.

Public health relevance
PUBLIC HEALTH RELEVANCE - This application would support continued postdoctoral training to young epidemiologists, behavioral scientists, geneticists and clinician-researchers who will become the next generation of scientists in pediatric cancer survivorship research. The training focuses on pediatric cancer survivorship and cancer control outcomes with research approaches informed by Global Health issues. Progress in these areas could have a major impact in reducing the burden of cancer and improving quality of life in cancer survivors.